Multi-scale Orbitofrontal Networks Underlying Reward Processing

? DESCRIPTION (provided by applicant): In substance abuse disorders, cravings and relapses can occur even after long periods of abstinence, posing a key challenge for successful long-term treatment. These phenomena arise when brain circuits that support reward-based learning and decision-making associate arbitrary cues with behaviorally reinforcing effects of drugs. The orbitofrontal cortex is a region crucial to reward-based decision-making, and has been strongly implicated in addiction. To date, it is known that the orbitofrontal cortex encodes the subjective value of predicted rewards, but the precise mechanism by which orbitofrontal networks use value information to inform learning and choice remains unclear. One theory suggests that orbitofrontal neurons combine multiple inputs, including sensory information to compute an abstract value, so that stimulus information contributes to orbitofrontal value coding in a bottom-up fashion. Another view holds that orbitofrontal cortex makes value-related predictions that influences downstream stimulus representations in a top-down fashion. Crucially, both accounts predict that orbitofrontal neurons encode value information; the distinction lies in how that information is used at a network level. Here, we will investigate how stimulus values are processed in both local orbitofrontal networks and broader functional circuits. To assess local network properties, we will use acute neurophysiology approaches in awake, behaving monkeys as they perform a reward preference task. We will record both single neurons and local field potentials, signals believed to reflect underlying network-level function, and focus on spatiotemporal dynamics in local field potentials, and their relationship to value-encoding neurons. To assess large-scale functional networks, we will record electrocorticography (ECoG) signals from the brains of human patients undergoing intracranial monitoring in preparation for epilepsy surgery. Patients will be tested in a reinforcement-learning task, while we simultaneously record from orbitofrontal cortex and anatomically linked sensory areas that process the stimuli used in the learning task. Over the course of learning, we will determine how orbitofrontal value representations interact with sensory stimulus representations. Overall, this work will use translational approaches to determine how orbitofrontal value coding relates to network-level activity at multiple scales, which could lead to novel therapeutic approaches for conditions of aberrant reward processing, such as addiction disorders. In addition, this proposal offers outstanding training potential. I will benefit from the expertise of two established mentors Dr. Wallis who specializes in non-human primate neurophysiology, and Dr. Chang, a neurosurgeon and researcher specializing in functional brain mapping and ECoG in human patients. Their training will help me build an independent research program that combines multiple approaches to understand how reward processing impacts higher cognitive abilities such as learning, memory and decision-making.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project focuses on understanding reward processing and decision-making in the orbitofrontal cortex at the level of local and long-range networks. Specifically, we will determine how stimulus-reward associations are encoded in the spatiotemporal structure of oscillatory potentials within orbitofrontal cortex and between orbitofrontal and sensory processing areas. These networks are strongly implicated in addiction disorders, and understanding how they process reward information will yield novel insights that could be used to advance therapeutic approaches.